Determining the role of afadin in tubular development and maintenance in the kidney

Project Summary/Abstract
Chronic kidney disease (CKD) poses an important global disease burden with limited therapeutic options. Novel
therapeutic strategies to improve renal function include implanting patient-derived kidney organoids onto the
native kidneys. However, an inability to connect organoid tubules with the host’s kidney tubules presents a major
problem that remains to be solved. Currently, the molecular mechanisms driving interconnection between tubules
and their lumens are poorly understood. Filling this gap in knowledge is critical to advance work with implantable
renal replacement tissues. Our previous studies have shown that mice lacking afadin, a cytoskeletal scaffolding
protein, from renal epithelial tubules, have a defect in lumen continuity. The goal of this project is to determine
how lumen connection/fusion occurs within tubules and determine the molecular mechanism by which afadin
promotes lumen fusion and maintenance in renal epithelia. We hypothesize that lumen fusion requires cellular
rearrangements and that these are facilitated by afadin-mediated regulation of cell-cell contacts. Here, I propose
to use well-defined in vitro and in vivo models to: (1) Determine the mechanism of lumen fusion after the onset
of de novo lumenogenesis, (2) Identify the afadin domains required for lumen fusion, and (3) Determine the role
of afadin in lumen maintenance in vitro and in an in vivo inducible knockout mouse model. The knowledge
obtained from these studies will enable a better design of epithelial structures that have the ability to form and
maintain a continuous lumen for future use as implantable therapeutics.

Public health relevance
Project Narrative Chronic kidney disease (CKD) is a significant global health problem with a critical need for novel therapies. Innovative attempts to use kidney organoids as implantable therapeutics are currently hindered by the inability of implanted organoid tubules to connect with tubules from the host kidney. The goals of this project are to study the processes leading to tubule interconnection, the role of afadin in promoting tubule continuity, and how tubule continuity is maintained in order to generate epithelial tissues to form effective conduits for renal replacement therapy.